Molecular Genetics Core

Project Summary
A Molecular Genetics Core will provide customized services for the production of transgenic and knockout
mice using the latest available technologies. Supported services include assistance with designing and
preparing constructs for gene targeting, viral vectors, establishing genotyping procedures for genetically-
modified mice, making recombinant DNA clones, constructing and validating DNA libraries for high-throughput
functional screens, in vitro fertilization (IVF) services, microinjection/electroporation of gene targeting
constructs and rederivation of mouse strains from cryopreserved stocks or pathogen-contaminated strains, and
sperm/embryo cryopreservation.
Provision of these support services and resources will greatly enhance the research capabilities of vision
investigators at Washington University and will facilitate collaboration among new and established vision
scientists.